CATECHOLAMINE REGULATION OF VASOPRESSIN IN HYPERTENSION

Catecholamine regulation of vasopressin in hypertension. The major aim of this proposal is to examine the role of catecholamine regulation of vasopressin in the supraoptic nucleus on the development and maintenance of hypertension. Secondary aims are the establishment of normal parameters of CA regulation of vasopressin and the identification of afferent nuclei and pathways to the supraoptic nucleus. The methodologies to be used will be specific and regional catecholamine depletions, immunocytochemical analyses, biochemical assays, and modulations of fluid content of the cardiovascular system. These experiments will be carried out on normotensive and hypertensive rats.